Neurodevelopmental Mechanisms Underlying Stress Vulnerability during Adolescence

Exposure to stressful life events (SLEs) is involved in the etiology of most forms of
psychopathology, and SLEs occurring early in development are particularly strong predictors of
mental health problems. Most adolescent disorder onsets are temporally preceded by a major
SLE. Yet, the mechanisms linking SLEs to the onset of adolescent psychopathology remain
poorly understood. Prior research on mechanisms linking SLEs with youth mental disorders has
focused largely on severe forms of adversity like abuse, neglect, and institutionalization. It is
unknown whether similar mechanisms are involved in the link between less severe SLEs and
psychopathology. Perhaps more critically, existing work has relied largely on cross-sectional
between-subjects designs that compare children with exposure to some type of SLE to children
without that experience. There is a dearth of longitudinal studies examining how SLEs influence
emotion, cognition, behavior, and neural circuits within-individuals over time in ways that predict
the emergence of psychopathology. The proposed research addresses this gap, using a novel
methodological approach that permits examination of dynamic changes in emotion, cognition,
social behavior, and neural function and connectivity following SLEs at a sufficiently fine grained
level of temporal specificity to identify mechanisms underlying the link between SLEs and
adolescent psychopathology as they unfold in real time. Specifically, the project will examine
how monthly fluctuations in exposure to SLEs within-individuals predict subsequent changes in
emotional processing in the Negative and Positive Valence Systems, Cognitive Control, Social
Processes, and neural function and connectivity over a 12-month period. In addition to monthly
assessments of SLEs, psychopathology, and potential mechanisms, passive monitoring of
activity, sleep, and social behavior (e.g., interaction with peers through text and social media)
through smartphones and wearable devices will allow additional mechanisms to be assessed
passively and without subject burden. The study will investigate whether monthly variation in
these emotional, cognitive, social, and neural processes predicts later increases in internalizing
and externalizing problems in an accelerated cohort design with monthly assessments spanning
age 11-18 years, producing 1,680 monthly observations over the study period. The longitudinal
design and high-frequency assessments are innovative in allowing the identification of
mechanisms that are altered by SLEs and prospectively predict psychopathology with high
temporal specificity during a developmental period associated with increases in SLE exposure,
stress vulnerability, and risk for psychopathology.

Public health relevance
The study will investigate whether monthly variation in these emotional, cognitive, social, and neural processes predict later increases in internalizing and externalizing problems in an accelerated cohort design with monthly assessments spanning age 11-18 years, producing 1,680 monthly observations over the study period. The longitudinal design and high-frequency assessments are innovative in allowing the identification of temporal specificity during a developmental period associated with increases in neighborhood level environmental exposures, stress vulnerability, and risk for psychopathology. Study findings will provide critical information regarding the specific domains of emotion, cognition, social behavior, and neural function that are altered by exposure to environmental risk factors and increase vulnerability to psychopathology.